Exploring heterogeneity of cognitive trajectories of preclinical Alzheimer's disease with digital phenotyping

PROJECT SUMMARY
The heterogeneous nature of Alzheimer’s disease (AD) manifestation and progression poses a significant
challenge to developing effective treatments. As a first step toward personalized medicine for AD, it is crucial to
identify clinically relevant subtypes, which will enable the creation of individualized interventions and healthcare
strategies. Cognitive function changes as people age, but there is considerable variability both between
individuals and across cognitive domains. Accurately characterizing these cognitive trajectories is particularly
challenging due to the limited availability of long-term, longitudinal data and the inherent complexity of
computational models needed to account for the multiple risk factors that influence cognitive decline.
Traditional neuropsychological (NP) tests often fail to capture the subtle and early changes in cognition that
precede a clinical diagnosis of AD. This gap underscores the need for more sensitive and continuous methods
of tracking cognitive decline over time. Recent advancements in digital voice (dVoice) recordings offer a novel
and highly efficient method for capturing cognitive-related measures and characteristics, providing continuous
data that may reveal subtle differences in cognitive processing. This project aims to leverage multimodal data,
including both traditional NP tests and dVoice recordings, to identify preclinical cognitive trajectories. By
incorporating a range of clinical risk factors, and utilizing the rich, longitudinal dataset from the Framingham
Heart Study (FHS), we aim to build a comprehensive model of cognitive progression. Cognitive domain scores
derived from NP tests will be complemented by composite scores representing different categories of non-
semantic acoustic features extracted from dVoice recordings. These scores will then be integrated into group-
based multi-trajectory models to map the progression of cognitive change over time. The primary research
objectives are: (1) to identify preclinical cognitive trajectories from multimodal measurements; (2) to examine
the association between these cognitive trajectories and incident AD, while investigating the specific risk
factors associated with membership in different cognitive trajectory groups; and (3) to develop machine
learning models that predict cognitive trajectories based on baseline measurements. We hypothesize that the
integration of non-semantic acoustic features with traditional NP tests will significantly enhance the precision of
cognitive trajectory modeling, offering new insights into the early stages of cognitive decline. By advancing the
understanding of cognitive trajectories and identifying key baseline factors that predict cognitive decline, this
project directly aligns with the objectives of the NIH R03 grant. It will provide valuable scientific insights that
have the potential to improve the prevention and diagnosis of individuals at risk of AD.

Public health relevance
Project Narrative The first step toward personalized medicine for Alzheimer's disease (AD) involves identifying clinically relevant subtypes, which are crucial for developing individualized interventions. This project aims to identify preclinical cognitive trajectories by integrating multimodal data, including neuropsychological tests and acoustic features from digital voice recordings, and to explore their association with incident AD and related risk factors. Additionally, machine learning models will be developed to predict cognitive trajectories, enabling a comprehensive understanding of the heterogeneity in AD progression.